Clinical Research Support Services for NIEHS Contract Task Order 1 - Core Function Activities

The purpose of this task order is to provide overall technical support and collaboration with activities associated with the Clinical Research Support Services for NIEHS contract. Under this task, the Contractor shall provide project administration and support to the work provided under other Task Orders in this contract.